Investigating Cerebellar Development in Ferrets: Implications for Modelling Human Cerebellar Development and Disease

PROJECT SUMMARY
While the human cerebellum is classically known for its involvement in motor functions, recent research has
implicated it in higher-order brain functions such as speech, language, and satiety. Across primate evolution,
the cerebellum has undergone significant expansion, housing 80% of human neurons. Yet, understanding its
development presents challenges due to unique human-specific features absent in commonly studied animal
models. Ferrets have emerged as a valuable model for studying various aspects of human brain development
due to several key similarities between their brain structure and development with that of humans, including the
presence of a gyrencephalic cerebral cortex. We recently identified several distinctive developmental traits in
the ferret cerebellum which partially mirror those found in humans. These include the presence of an expanded
dorsal progenitor zone called the rhombic lip (RL) which produces all cerebellar Glutamatergic neurons.
Compared to rodents like mice and rats, we also observe an expansion in cycling Tbr2+ cells which we
recently implicated in the pathogenesis of Medulloblastoma Groups 3 and 4. Notably, our preliminary data also
indicates that the ferret RL shares characteristics such as longevity throughout gestation and molecular
complexity similar to the human RL, setting it apart from rodents and non-human primates. Despite these
parallels, we know very little about cerebellar development in ferrets and the mechanisms driving the ferret-
specific expansion of the cerebellar progenitor zones remain elusive necessitating a more comprehensive
analysis. This study aims to elucidate this process by characterizing all primary and secondary cerebellar
progenitor zone in ferrets throughout development. Utilizing immunohistochemical and in situ hybridization
assays, alongside single-cell/nucleus multiomic analyses, we seek to unravel the molecular pathways
governing cerebellar development in ferrets. Furthermore, by studying the ferret cerebellum in the context of
human and mouse development, we aim to identify unique as well as shared molecular programs. Leveraging
our expertise in cerebellar development across multiple species, including ferrets, and our access to unique
samples of normal ferret tissue, obtained through collaborative efforts, this study promises to shed light on the
intricacies of ferret cerebellar development and its utility as a potential model to study human cerebellar
disease.

Public health relevance
PROJECT NARRATIVE Cerebellar development is a critical in the context of neurological maturation as the cerebellum controls motor coordination, cognitive processing, and even emotional regulation. While much is known about cerebellar development in rodents, there remains a significant gap in our understanding of cerebellar development in intermediate mammalian species like ferrets which have been shown to possess a number of human brain developmental features not observed in the rodent or fish model. This grant proposal therefore aims to explore ferret as a model to study cerebellar development and compare it with human and mouse development, shedding light on evolutionary conserved mechanisms and species-specific adaptations.